Core 3: Biostatistics and Bioinformatics

PROJECT SUMMARY/ABSTRACT: Biostatistics and Bioinformatics Core
The purpose of the Biostatistics and Bioinformatics Core (BBC) is to provide professional expertise in
biostatistics and bioinformatics for all Vanderbilt-Ingram Cancer Center SPORE in Gastrointestinal (GI) Cancer
projects, investigators, and participants. Functions provided by this core include development of experimental
designs, power analysis and sample size estimation, data quality control, statistical/bioinformatics analysis and
interpretation of findings, and collaboration on presentation of results. To achieve these functions, the core
director and core members are constantly available to investigators, with key biostatisticians and
bioinformaticians assigned to each project, and all are in regular contact with the project and core leaders.
The primary objectives of the BBC are:
1. To provide study design and review all laboratory, animal, translational, epidemiological, and clinical
studies including feasibility assessment, power analysis, and sample size estimation;
2. To collaborate in project data analysis including bioinformatic pre-processing analysis, interpretation of
results, and the writing of final study reports and manuscripts;
3. To work with the Tissue Pathology and Cellular Analysis Core and Mouse and Human Molecular Imaging
Core in the development of research project databases, to maintain data quality control and to ensure
timely data capture;
4. To develop and evaluate statistical/bioinformatic methods for experimental design and data analysis.
BBC support is required in all VICC GI Cancer SPORE studies, with biostatisticians and bioinformaticians
assigned to each project. Core personnel have worked and will continue to work closely with project leaders to
ensure the core provides state-of-the-art statistical /bioinformatic support.

Public health relevance
PROJECT NARRATIVE: Biostatistics and Bioinformatics Core The relevance of the Biostatistics and Bioinformatics Core (BBC) lies in our provision of services essential for the conduct of high-quality collaborative gastrointestinal cancer research. Sound biostatistical/bioinformatic inputs are provided throughout the lifespan of a research project, from conception to completion. To ensure the needs of the investigators are met thoroughly and efficiently, key biostatisticians and/or bioinformaticians are assigned to each project.